Synthetic biology to discover kratom natural product biosynthetic pathways for biased analgesic development

Project Summary
Opioid alternative analgesics that would kill pain potently without the respiratory side effect will be of
specific importance in addressing the opioid crisis. The medicinal herb kratom (Mitragyna speciosa) produces
natural products (mitragynine and 7-hydroxymitragynine) that selectively activate analgesia only, which are
promising “biased” opioid alternatives. Elucidating the kratom biosynthetic pathway composed of enzymes
catalyzing sequential reactions toward the syntheses of mitragynine, 7-hydroxymitragynine, or other kratom
products is important to the development of “biased” non-opioid analgesics. We propose to identify and
reconstruct both the kratom biosynthetic pathways and the plant enzyme complexes organizing plant
biosynthesis in yeast by integrating plant functional genomics analysis and synthetic biology. The research will
provide new chemical and plant biology knowledge to a broader community, develop a post-translational level
understanding of plant pathway regulation in yeast, and highlight the possibility of using synthetic biology to
understand how nature achieves complicated natural product biosynthesis.
This proposal will develop the conceptual framework to understand how nature organizes the specialized
metabolism in plant toward high efficiency and complexity. The development of high-throughput protein-protein
interaction method in yeast for plant complex identification will provide new methods and knowledge for plant
pathway discovery and reconstruction. The methods and knowledge we develop toward these goals will also
enable the structural elucidation, biological activity evaluation, and microbial production of biased opioid
alternatives, leading to the development of next-generation painkillers to address the opioid crisis.

Public health relevance
Project Narrative The project aims to elucidate and reconstruct the biosynthetic machinery of kratom natural products in yeast for novel non-opioid analgesic development. It will address the longstanding question in plant metabolism about the role plant enzyme complexes play in regulating complicated biosynthesis. This work will provide new methods to discover novel plant complexes and the pathways they organize and ultimately advance pharmaceutical compound biosynthesis for “biased” non-opioid analgesics as the next-generation painkillers.